Understanding heterogeneity of necroptotic cell death and mechanism(s) of necroptosis escape

Summary
Receptor-interacting Protein Kinases 1 and 3 (RIPK1 and RIPK3) form necrosomes that, along with Mixed
Lineage Kinase Domain-like (MLKL) pseudokinase protein, are well-established mediators of a regulated
necrotic cell death process, known as necroptosis. Dysregulation of necroptosis has been implicated in many
disease states, including inflammatory pathologies and cancer. Besides cell death, necrosome-driven pro-
inflammatory transcriptional changes that are independent of cell death and the release of pro-tumorigenic
DAMPs, cytokines, and chemokines by the dying cells can also drastically affect outcomes of necroptosis
activation. Thus, how these diverse orthogonal processes intermingle in a heterogeneous population of cells
undergoing necroptosis is crucial to understand. In addition, our new data show that upon activation of
necroptosis in multiple necroptosis-sensitive human cancer cell lines, a subset of cells quickly develops an
irreversible resistance to necroptotic stimuli and survives, which also needs to be accounted for when
considering the outcomes of necroptosis activation. In our preliminary work, we used bulk transcriptomics of
necroptosis-resistant clones to demonstrate systemic transcriptional shifts in cells upon acquisition of resistance
to necroptosis. However, bulk approaches are generally not well suited for understanding cell death dynamics
in a heterogeneous cell population. Instead, single-cell methods are needed to interrogate transcriptional
signatures in cells undergoing necroptosis vs. developing resistance and surviving the insult. To address this
gap, in Aim 1, we propose to validate and optimize a new assay format that we created, scAnnexinV-seq,
allowing co-measurement of cell death status and short-term inflammatory gene expression changes with single-
cell resolution in a cell population that is asynchronously undergoing necroptosis. These experiments will be
done in human monocytic U937 cells. In addition, we will also examine, using scRNA-seq, gene expression
patterns associated with a longer-term transition of these cells to a necroptosis-resistant state. Aim 2 will deploy
a single-cell DAMP release assay to measure the dynamics of DAMP release and cell death in a necroptotic cell
population. For this analysis, we will use cells with different degrees of acquired resistance to necroptosis from
Aim 1 to examine whether a slower rate of cell death in cells transitioning toward resistance may lead to a
prolonged pro-tumorigenic DAMP release. In addition, we will examine the roles that several specific factors
involved in the regulation of necroptosis may have on the dynamics of DAMP release vs. cell death. The findings
from this work will be impactful in developing new tools and elucidating population dynamics in necroptotic cells,
thereby revealing new inflammatory mechanisms associated with necroptosis and cell trajectories toward
necroptosis escape that may be highly relevant for inflammatory diseases and cancer.

Public health relevance
PROJECT NARRATIVE Necroptosis is a robust form of regulated cell death, which is proposed to contribute to a wide range of human diseases. However, for the reasons that are incompletely understood, individual cells in a population display highly varying sensitivities to necroptosis. We will analyze mechanisms of the heterogeneity of necroptosis, which will be highly relevant for human diseases involving both excessive necroptosis, which happens in many degenerative conditions, and cellular resistance to necroptosis, which is observed in cancer.